Research conference titled "Building and Crossing the Translational Bridge in Alopecia Areata"

PROJECT SUMMARY/ABSTRACT: This research meeting ?? “Building and Crossing the Translational Bridge in Alopecia Areata” ?? is designed to share findings and distill learning from the most current research advances and set strategic research priorities for the next two to five years to hasten progress in finding a viable, accessible treatment for this autoimmune skin disease that affects 2.1% of the population. Alopecia areata is a disease characterized by hair loss and emotional pain that affects 6.6 million Americans of all ages, races and ethnicities. There are no treatments approved by the FDA for this common disfiguring disease. Although alopecia areata does not reduce life expectancy, it is a disability that results in unfair discrimination, like being bullied for looking different, expelled from school for wearing a hat to keep the head warm or being fired from a job at a hotel for wearing a headscarf because a hair prosthesis was prohibitively expensive. These are true and recent stories. This two‐day meeting designed to blend concise informative presentations about the newest developments with meaningful discussion among established senior scientists, new investigators and patients who stand to benefit will be led by three esteemed medical and scientific co‐chairs: Angela Christiano, PhD, of Columbia University; Maria Hordinsky, MD, of the University of Minnesota; and, John Harris, MD, PhD, of the University of Massachusetts Worcester. Proceedings will be held each day with a patient and industry roundtable dinner between. Presentations of 10–15 minutes will be followed by lengthy Q&A sessions designed to foment substantive discussion. The conference will conclude with consensus‐building about priorities for research in the next two years and beyond. Progress on research goals set at the 2014 summit which was supported by NIAMS and NCATS will be reviewed, including specific advances in genetics, immunology, animal models, imaging techniques and clinical investigation. New developments spearheaded through projects supported by the NIH ?? in cross‐cutting autoimmune and dermatologic research, immunology of the skin and microbiome ?? as well as identification of targets and new collaborations with biopharmaceutical companies will be reviewed. Presentations on patient‐centered outcomes will also be included. The goals of the meeting are to: efficiently generate rapid progress for alopecia areata research; strengthen ties and increase understanding and benefit between alopecia areata researchers and those focused on related skin and autoimmune diseases; improve partnerships with key government agencies; spark innovation and collaboration; and set priorities which will inform research grant‐ making by the National Alopecia Areata Foundation and other funders of alopecia areata research.

Public health relevance
PROJECT NARRATIVE: If this research meeting achieves the long‐term goal of leading to a safe, effective, accessable treatment or cure for alopecia areata, the public health burden for the 6.6 Million Americans living with this disease will be reduced or eliminated.